Neural Mechanisms of Depressive Symptoms in Youth with Autism SpectrumDisorder

PROJECT SUMMARY/ABSTRACT
Autism spectrum disorder (ASD) is common (1 in 59 US children) and impairing. Yet, co-occurring
psychiatric disorders—especially depression—in ASD remain understudied, hindering clinical care. This K23
seeks to address an important gap in knowledge about the neural mechanisms underlying depressive
symptoms in ASD, which could ultimately provide a precision medicine-based approach to novel treatment
development. Our central hypothesis is that depressive symptoms in adolescents with ASD will be associated
with fronto-limbic, fronto-frontal and fronto-thalamic connectivity that, in turn, are related to underlying
differences in white matter integrity and myelination. Our central methodology is to scan n=40 children (ages
12-16) with ASD and n=40 age-matched controls without ASD. The research goals of this K23 are to: (i)
identify resting-state functional magnetic resonance imaging (rs-fMRI) correlates of depressive symptoms in
ASD; (ii) investigate white matter microstructural alterations linked to depressive symptoms in ASD; (iii) utilize
connectome-based approaches to explore the interaction between depressive symptoms across modalities.
My career development goals are to gain expertise in: (i) rs-fMRI (and deeper understanding of promising
circuit-based approaches to target engagement); (ii) diffusion spectrum imaging/myelin imaging; (iii) research-
grade diagnostic evaluation of ASD; (iv) characterization of mood disorders in individuals with ASD; and (v)
professional development to become an independent investigator. This proposal is significant because it will
address NIMH Strategic Plan Objective 1.3 to characterize neural circuit mechanism disruption underlying
depressive symptoms in ASD, using neuroimaging and detailed psychopathology phenotyping. This K23 is
innovative because it will be the first to use multimodal imaging methods, including rs-fMRI, diffusion spectrum
imaging, and myelin imaging, to define neural mechanisms of depressive symptoms in a sex-balanced sample
of adolescents with ASD. Leveraging vital data and career development from this K23, I will submit future
R01s as an independent investigator that focuses on: (i) deeper understanding of the neural mechanisms of
co-occurring depressive disorders (including major depressive disorder, persistent depressive disorder) in
individuals with ASD, and (ii) examination of how circuits change across development (expanding the age
range to early childhood and young adulthood) in individuals with ASD with or without depressive disorders.

Public health relevance
PROJECT NARRATIVE While autism spectrum disorder (ASD) is common and impairing, our lack of knowledge about the mechanisms underlying co-occurring depression in people with ASD hinders clinical care and effective treatments. This K23 seeks to address this gap, defining brain mechanisms associated with depressive symptoms in adolescents with ASD compared to controls, leveraging multimodal imaging methods (resting- state functional magnetic resonance imaging, diffusion spectrum imaging, and myelin imaging). This work is significant because it will create the foundation for future studies defining how the brain mechanisms of co- occurring depressive disorders in individuals with ASD change across development, and, ultimately, to develop novel brain-targeted treatments for depression in people with ASD.